NIEHS Cryo-EM Core Facility

Single-particle cryo-electron microscopy (cryo-EM) is a powerful technique to determine the structure of macromolecular complexes at high resolution. It circumvents the need to crystalize samples for X-ray crystallography, requires limited quantities (nanogram) of purified material and can provide near atomic resolution information on large and dynamic structures. NIEHS is collaborating with Duke and UNC Chapel Hill to establish the Molecular Microscopy Consortium (MMC). The Consortium was envisioned as an association between three imaging facilities, one for each institution (Duke, UNC and NIEHS). The operation is unified by a single closely connected core team providing expertise in data acquisition, training and support in specimen preparation and in image processing. The facilities were expected to become operational in the course of two years. NIEHS led the effort by building the Cryo-EM Core in record time. Its FEI Talos Arctica cryo-electron microscope was fully operational in June 2017, nine months after placing the order. During its first three quarters of operation, structural biologists from over a dozen of groups were trained in specimen preparation, conducting over a hundred screening sessions which lead to the identification of conditions suitable for high resolution data collection. Initial structures were obtained from data collected at the Talos Arctica. The first, a structure of the Thermoplasma acidophilum proteasome core particle at 3.2 was solved independently in November 2017 by Allen Hsu, a IRTA post-baccalaureate with no previous experience in Cryo-EM who started training at the core five months earlier. This result demonstrated both the quality of the data available from the instrument and the validity of the approach of collaborative training. The Duke cryo-EM facility, equipped with a top-of-the-line FEI Titan Krios, was deployed in mid-April of 2018. This greatly accelerated the data collection on specimens that had been previously optimized at the NIEHS facility. In less than four months, data from the Krios lead to the solution of ten additional structures in the range of 3 to 5 (Table). The instrument has been operating in data collection mode uninterrupted 24 hours a day, seven days a week since its deployment. Many other projects are steadily progressing through the optimization process and are expected to yield new structures in the near future. Using their own data, collaborators from different groups were trained in the utilization of software to solve their own structures. In a relatively short period of one year, several laboratories are now capable of independently optimizing specimen preparation and, once high-resolution data is collected, of solving their own structures. This further demonstrates the viability of collaborative training supported by an organization providing high quality data. Table: Structures solved at the MMC during FY2018 Robin Stanley, NIEHS, RNA binding protein (3.5 ) Robin Stanley, NIEHS, AAA+ ATPase (4.5 ) Seok-Yong Lee, Duke, six distinct channel structures (3.3 4.3 ) Barton Haynes , Duke, HIV envelope glycoprotein in complex with various Fabs (5 ) Maria Schumacher, RNA Polimerase ( 3.5 ) Rob McGinty, Nucleosome Core Particle in complex with methyltransferase (3.6 )